ADRD spousal caregivers, loneliness, & immune dysregulation: Real-Time, real-world intervention targets

Caregiving for a spouse with Alzheimer's disease or a related dementia (ADRD) is among life's most stressful
experiences and is characterized by caregiver burden, grief, and higher rates of morbidity and premature
mortality. Yet, there is considerable unexplained variability in ADRD spousal caregivers' mental and physical
health patterns. ADRD spousal caregivers are prone to social isolation and loneliness, two separate but related
constructs thought to fuel physical and mental health problems in ADRD spousal caregivers. Very little is known
about how loneliness, social isolation, and their temporal dynamics and interactions play out in real-time in the
real-world. This is unfortunate because dementia spousal caregivers' experiences of objective social isolation
and loneliness, and their concurrent physiological state, are constantly changing in real-time based on a
constellation of temporal dynamics, proximal momentary factors (e.g., location, time, tasks/stressors, quality and
type of recent social interaction), trait-like patterns of relational expectations, emotions, and behaviors (e.g.,
attachment orientations), and sociocultural conditions. A socio-culturally diverse cohort of 300 ADRD spousal
caregivers will answer questions about their mental wellbeing (caregiver burden, depression & grief) and provide
blood to evaluate proinflammatory cytokine and two related determinants of inflammatory phenotypes, cellular
aging, and disease (i.e., mitochondrial, and glycolytic function) at baseline, and during two follow-up visits (2
weeks and 6 months after baseline). They will also provide intrapersonal and socio-contextual data by self-report.
During a 2- week gap between visits 1 and 2, a 14-day ecological assessment will provide momentary data on
loneliness, depressive affect, momentary context (e.g., current location, social context, daily activities, caregiving
and non-caregiving stressors. Using a sophisticated smartwatch we successfully piloted in ADRD spousal
caregivers, we will continuously evaluate vagally mediated heart rate variability. Aim 1 models the momentary
associations between loneliness, depressive affect, and vagally mediated heart rate variability; Aim 1 will also
model the impact of loneliness (both severity and variability) on indices of ADRD spousal caregiver mental
wellbeing (caregiver burden, depression & grief), and physical health (inflammation, mitochondrial and glycolytic
function) over time. Aim 2 investigates whether associations between momentary loneliness, ADRD spousal
caregiver mental wellbeing, and physical health indices are modified by momentary context, and relatively stable
indices of intrapersonal (i.e., attachment orientation) and contextual (i.e., sociocultural conditions) factors. Aim
3 (exploratory) models the impact of vmHRV on indices of ADRD spousal mental care wellbeing (caregiver
burden, depression & grief), and physical health (inflammation, mitochondrial and glycolytic function) over time.

Public health relevance
This study will provide critical information about daily patterns of vulnerability that can be used as intervention targets for ADRD spousal caregivers.